OXYGEN THERAPY FOR MODERATELY SEVERE RETINOPATHY OF PREMATURITY

To determine if supplemental theraputic oxygen will reduce the proportion of infants with pre-threshold ROP that advance to threshold ROP. Also to determine the impact of this treatment on rates of growth, pulmonary status, and length of stay.